Administrative Core

Abstract/Summary Administrative Core
The Administrative Core is responsible for the administrative planning, oversight, implementation, and
management of the Center. The primary role of the Administrative Core is to achieve integration across
projects and cores, foster synergy, manage risks, support researchers and students in effectively conducting
research and translating that research, as well as maximizing the expertise and diversity of voices of advisors,
cores, and consultants. The specific aims of the Administrative Core include: (1) facilitate the work of Center
investigators; (2) organize regular meetings and information sharing opportunities enhancing collaboration and
efficient problem solving across the Center; (3) engage the advisory boards to assist with review and counsel
for the Center's activities; (4) monitor and evaluate the progress being made; and (5) promote inclusivity of
diverse perspectives. The Center has been productive for the last 15 years and we view this cycle as the
opportunity for translation of the cumulative foundational work already done with the addition of some related
new ideas. In this cycle we will build upon the basic and applied research of the past with a special emphasis
on planful dissemination and implementation (Brownson, et al 2018). While we have worked to include those
populations traditionally underserved in the past 15 years, this cycle will take a more focused and targeted
approach to ensure that our research reaches and positively impacts these populations.